RARE BOOK CONSERVATION

The objective of this project is to carry out conservation treatment on volumes in the rare book and manuscript collections of the History of Medicine Division of the National Library of Medicine, in order to return these volumes to usable condition, preserve them from further damage, and extend their life expectancy for several hundred more years.